ASSESSMENT OF DRUG USE &ABUSE AMONG HISPANICS

The objective of the proposed research is to examine the efficacy of several psychological assessment procedures in measuring drug use and abuse among Hispanics. The specific aims are: (1) to assess the reliability and validity of the Diagnostic Interview Schedule (DIS) when used in English and Spanish with Hispanics and in English with Anglos; (2) to assess whether the phenomenology of selected disorders (e.g., drug abuse, alcohol abuse, antisocial personality disorder, anxiety, depression) varies by attributes such as language (English/Spanish), ethnic status (Anglo/Hispanic), and acculturation; and (3) to assess the reliability, validity, and utility of two brief screening instruments relevant to studies of substance abuse, the HHANES/NIDA questionnaire on drug use and the Center for Epidemiologic Studies Depression Scale (CES-D), when used in English and Spanish with Hispanics and in English with Anglos. Study subjects will consist of a sample of 192 patients participating in a drug abuse treatment program, a comparison group of 160 patients participating in an alcohol abuse treatment program and a second comparison group of 247 patients in treatment for general (nondrug, nonalcohol) psychiatric dysfunction. The design involves assessing Anglos, monolingual English-speaking Hispanics, monolingual Spanish-speaking Hispanics and bilingual Hispanics. This latter group was randomly assigned to English and Spanish interviews. The DIS will assessed for test-retest reliability, concordance (i.e., sensitivity/specificity) between the DIS, the hospital/clinic chart diagnosis, and a diagnosis made using the DSM III Checklist by a research team clinician blind to the other two diagnostic outcomes. Concordance between this latter diagnosis and the medical record diagnosis also will be examined. Differential manifestation of drug use/abuse will be examined using multivariate classification procedures (cluster analysis, confirmatory factor analysis, latent trait analysis) to analyze symptom patterns within diagnostic groups and across diagnostic groups as a function of ethnic status, language and acculturation. The screening instruments (CES-D and HHANES/NIDA) will be assessed using item nonresponse, test-retest and internal coinsistency reliability and also sensitivity/specififity using as the criteria DSM III diagnoses of drug abuse from the three clinical sources: the lay-administered DIS, hospital/clinic medical record, and research staff clinician using the Checklist.